Continuation of the Childhood Liver Disease Research Network Seattle Clinical Center

Project Summary/Abstract
Biliary atresia (BA) and the other childhood cholestatic liver diseases are significant causes of chronic
liver disease in children, and the leading causes for liver transplantation in pediatrics. The initial funding
periods leading to the current Childhood Liver Disease Research Network (ChiLDReN) have resulted in
unprecedented collections of well phenotyped subjects and banked data and biological specimens. Although
ongoing recruitment of subjects with these rare conditions is needed to allow full attainment of many of the
individual study Aims, the collection of subjects, data, and biospecimens is now sufficient to support
meaningful investigation into the pathogenesis of these diseases and allow thorough genomic screens to
elucidate etiologies and modifiers of disease phenotypes. This next funding period will allow completion of the
ongoing studies and add study of primary sclerosing cholangitis. Furthermore, in conjunction with completing
the ongoing studies, such as PUSH, identification of predictors of liver disease development will be possible
via the approved ancillary trial of non-invasive markers of disease (led by Dr. Murray). The Seattle Clinical
Center (CC) has the experience, expertise, and proven track record to continue participation in ChiLDReN, and
has the expected patients over time to support the ongoing and new consortium trials.
Dr. Murray and her CC team has additionally proposed a Pilot and Feasibility Trial to study the impact
of parenteral nutrition, with standard intralipids versus Omegaven, on malnourished children with end-stage
liver disease due to BA. This study has the potential to change the standard of care for these vulnerable
patients, improve their outcomes, and enhance our understanding of the pathogenesis of this obliterative
cholangiopathy.
Furthermore, to better understand the etiology of BA and potentially identify unique underlying
candidate genes, Dr. Murray also proposes to perform whole genome sequencing and rare-variant analysis on
a subset of the ChiLDReN BA trios to identify variants of both large and small effects in families with BA and
ductal plate configuration.

Public health relevance
Project Narrative Biliary atresia and the other cholestatic liver diseases of childhood are important causes of pediatric liver disease, morbidity, and mortality and are the leading causes for liver transplantation in childhood. The ChiLDReN network will allow for an unprecedented advancement in our knowledge of these conditions, the pathogenesis of pediatric cholestatic and fibrosing liver diseases, and advancement in the treatments available for these children.